Next generation free energy perturbation (FEP) calculations--enabled by a novel integration of quantum mechanics (QM) with molecular dynamics allowing a large QM region and no sampling compromises

Project Summary
The value of computational chemistry to commercial drug discovery is now well-established. Virtual screening
(including molecular docking) now jumpstarts most discovery efforts. More recently, a combination of GPU and
cloud based computing has vastly increased the realistic computational throughput available for drug
discovery. In turn, this has ignited substantial interest in relative free energy calculations (e.g. Free Energy
Perturbation, FEP) for drug lead enhancement. FEP has been applied at the fringes of drug discovery for
decades, but massive parallelism in the more recent past has moved FEP to center stage, and FEP has
helped shave months or years off discovery efforts where these calculations are reliable.
The catch is that FEP calculations are not always reliable. While for some systems, the error in a FEP result is
much less than one kcal/mol--and they have successfully steered slow/expensive bench efforts--there are
other systems where the predictions are not very useful. Even where retrospective analysis is possible, it is
often not very clear why FEP calculations are so good for some target systems, and so bad for others. Broadly,
the limitations of FEP can be distilled down to three problems: A poor description of the energetics (force field);
insufficient sampling; or a misunderstanding of the fundamental science (e.g., incorrect protein model, wrong
binding site, wrong protonation state, etc.). It is generally believed that many issues arise from the first of
these—and improving the evaluation of energetics using quantum mechanics (QM) will be the focus here.
There is a huge interest in methods that can help obviate the existing problems with FEP. Herein, we propose
a new platform for FEP, which incorporates a quantum mechanical description of the molecular interaction of
central interest. The traditional force field used with FEP is a simplified analytic expression with fit coefficients
termed Molecular Mechanics (MM). MM is a simple approximation of the true molecular interactions that can
be described using quantum mechanics. But QM has been, until recently, far too expensive to use in the
context of the molecular dynamics (MD) sampling required for FEP.
At long last, we have determined how to integrate QM into the FEP paradigm, using a carefully programmed
distributed processing platform that lends itself to use on commodity cloud computers, and by integrating a
semiempirical QM implementation that provides predictions that are much better than those from MM, but at a
cost far less than for a full DFT QM prediction. Our implementation allows FEP calculations with a realistic QM
core region of hundreds of atoms to be carried out with the scale of sampling associated with accurate FEP
calculations and with turnaround commensurate with modern drug discovery. Here, we propose to validate this
platform against traditional MM-based FEP, to show it addresses many of the issues of that approach. We will
also identify additional implementation ideas to further improve effective throughput and/or accuracy.

Public health relevance
Project Narrative Computational chemistry has vastly improved the speed and reliability of drug discovery, and the relative free energy calculation method FEP has had a huge effect on the hit-to-lead phase of such discovery—providing an approach that can predict the effects of drug modification with usable accuracy for many receptors. That said, FEP does not currently work well for many systems, for reasons that are believed to reflect limitations of the analytic energy function that has traditionally been at the core of how this approach is implemented. We describe a new, novel, approach that for the first time circumvents these limitations through the use of quantum mechanics, and in this grant we propose carrying out work to validate and improve the method.